Hedgehog Signaling in Kidney Homeostasis and Repair

DESCRIPTION (provided by applicant): Acute and chronic kidney injury exacts a profound and growing toll on the health of Americans. The kidney possesses an impressive capacity to repair itself after many forms of acute injury, and a deeper understanding of the cellular and molecular mechanisms of this process will identify new therapeutic approaches to treat human suffereing from kidney failure. Members of the Hedgehog (Hh) family of secreted signaling molecules regulate cell proliferation, differentiation and tissue patterning. They play important roles during nephrogenesis and in other organs are increasingly appreciated as regulators of tissue regeneration. This proposal will investigate the role of hedgehog ligands in kidney homeostasis and repair. Two Hh ligands are expressed in kidney, Indian hedgehog (Ihh) and Sonic hedgehog (Shh), and these are expressed by tubular epithelial cells. Hedgehog responsive cells are located adjacent to epithelia, in the renal interstitium. We hypothesize that crosstalk between Hh-producing epithelia and Hh-responsive interstitial cells maintains cellular differentiation during homeostasis, whereas kidney injury upregulates Hh signaling triggering tissue repair, or if the injury is ongoing, resulting in maladaptive interstitial fibrosis. In Aim 1, we will characterize at the cellular level the expression of Hh pathway components, and examine whether pharmacologic inhibition of Hh signaling during acute injury results in a delay in the re-differentiation of renal epithelia. In Aim 2, we use pharmacologic and genetic gain or loss-of-function approaches to activate or inhibit Hh signaling during acute and chronic renal injury to assess whether modulation of the Hh pathway might represent a novel therapeutic target. In Aim 3, we will specifically address the mechanism by which Hh signals exert their effects in kidney using pericyte cell culture models and we employ in vivo pericyte fate mapping to test whether Hh-responsive cells expand and differente into scar forming myofibroblasts during chronic injury.

Public health relevance
PUBLIC HEALTH RELEVANCE: The increasing prevalence of chronic kidney disease in our aging population represents an enormous health burden. Because the final common pathway for most chronic nephropathies is renal fibrosis, therapies that reverse or even slow fibrosis would have tremendous clinical impact. These studies will explore the role of a signaling pathway called Hedgehog. Drugs are now being developed to modulate this pathway, so these studies might identify a new use for such drugs in treating kidney fibrosis which remains a tremendous problem in the United States and worldwide. Project Narrative: The increasing prevalence of chronic kidney disease in our aging population represents an enormous health burden. Because the final common pathway for most chronic nephropathies is renal fibrosis, therapies that reverse or even slow fibrosis would have tremendous clinical impact. These studies will explore the role of a signaling pathway called Hedgehog. Drugs are now being developed to modulate this pathway, so these studies might identify a new use for such drugs in treating kidney fibrosis which remains a tremendous problem in the United States and worldwide. __SpecificAimsTextDelimiter__ A. HYPOTHESIS AND SPECIFIC AIMS Members of the Hedgehog (Hh) family of secreted signaling molecules regulate cell proliferation, differentiation and tissue patterning. This proposal will investigate the role of hedgehog ligands in kidney homeostasis and repair. Indian hedgehog (Ihh) is expressed in the adult proximal tubule, the nephron segment most susceptible to ischemic and toxic injury. Sonic hedgehog (Shh) is expressed in collecting duct epithelia. Preliminary findings from our lab indicates that Hh responsive kidney cells are interstitial pericytes, a mesenchymal cell type that during chronic kidney injury differentiates into the myofibroblast, the scar-forming cells that cause fibrosis. We have initiated studies to elucidate the functional roles of Hh signaling in kidney injury and repair, and find that Hh inhibition retards repair from acute kidney injury whereas Hh signaling is dramatically upregulated in chronic fibrotic renal injury. We hypothesize that (1) epithelial Hh signals to interstitial pericytes, and this crosstalk maintains the terminally differentiated state of proximal tubule epithelia during homeostasis, (2) that acute injury upregulates epithelial Hh signals, triggering a repair program, and (3) that prolonged injury is associated with continuously elevated Hh signals that trigger maladaptive pericyte proliferation and differentiation into myofibroblasts, leading to renal fibrosis. Using genetic and pharmacologic tools, we propose three specific aims to identify the functional roles of Hh signaling in epithelial repair and pericyte proliferation: Aim 1. To characterize at cellular resolution the adult kidney expression patterns of Hh pathway ligands Ihh and Shh, Hh receptors Ptc-1 and Smo and transcriptional effectors Gli1-3 using high resolution in situ analysis, immunohistochemistry and reporter mice during homeostasis, injury and repair. To determine whether Hh inhibition by cyclopamine during kidney repair is associated with sustained S3 segment expression of the dedifferentiation markers vimentin, Kim-1, NCAM and Pax-2. Aim 2. To determine whether Hh pathway activation regulates kidney repair and fibrosis using pharmacologic and genetic loss- or gain-of-function approaches. We will use the Hh agonist purmorphamine and the Hh antagonist cyclopamine in vivo. We will genetically activate Hh signaling in pericytes using a conditional constitutively active SmoM2 mutant (W539L) or inhibit kidney Hh signals using a novel conditional Hh antagonist (Hhip-1) in pericytes or epithelia and examine the functional consequences during homeostasis and repair. Aim 3. To test the hypothesis that interstitial pericytes respond to injury-induced epithelial Hh signals by secreting reparative angiogenic factors, proliferating and differentiating toward the myofibroblast lineage. We will use in vitro pericyte culture, in vivo Col1α1-GFP reporter mouse and Gli1- pericyte fate-tracing approaches to define the functional importance of Hh signaling to pericytes in mediating myofibroblast proliferation and differentiation. Together, these aims will define the role of Hh signaling between kidney epithelia and pericytes, and advance our understanding of the biology of injured epithelial cell communication with its microenvironment. These studies will additionally establish new mouse genetic tools useful to the scientific community, and evaluate the Hh pathway as a novel therapeutic target in the treatment of acute and chronic kidney diseases.